Multidisciplinary Training in Ethnic Diversity and Cancer Disparities

At the root of health disparities is the diversity in the biological, social, cultural, behavioral, and economic
characteristics of individuals and populations. The study of ethnic/racial disparities begins with an
understanding of the characteristics of each group and how these characteristics affect cancer development
and outcomes. This new application for a joint T32 postdoctoral training program at University of Hawaii
Cancer Center (UHCC) and the University of Southern California (USC) Norris Comprehensive Cancer Center
(NCCC) addresses cancer health disparities utilizing a unique resource, the Multiethnic Cohort (MEC) Study, a
population-based prospective cohort study that has followed African Americans, Native Hawaiians, Japanese
Americans, Latinos, and whites for the past 25 years. Linkages to cancer registries, Medicare, and other data
sources provide a variety of endpoints for MEC and many other cancer disparity studies conducted at both
institutions. The complementary research at UHCC and USC is supported by cutting edge cores and benefits
from many years of experience. The specific aims of the proposed training program are:
1. To train postdoctoral fellows for independent careers in cancer research in diverse populations, with a
specific focus on the sociocultural, nutritional, lifestyle and biological risk factors leading to cancer health
disparities in a variety of ethnic/racial minorities. This program is highly unique and will leverage the long-
standing (30+ years) collaboration between research programs at two NCI-designated Cancer Centers to
permit a broader experience in training and tools for epidemiological research.
2. To provide extensive applied research experience in a multidisciplinary environment focusing on nutritional,
molecular, genetic and translational epidemiology that builds on multiple unique racial and ethnically
diverse studies of cancer. Together with strong mentorship, these studies will serve as the centerpiece for
an effective transdisciplinary training, which will allow trainees to design innovative high-impact projects,
and will prepare trainees for careers in cancer health disparities research.
During the 5-year grant period, the training program will educate 8 postdoctoral fellows in Hawaii and 10 in Los
Angeles. All trainees will be exposed to a wide range of innovative molecular and traditional cancer prevention
approaches (epidemiology, biomarkers, genomics, and nutrition) to address a wide range of cancer disparity
research questions across the ethnic/racial populations in Hawaii and California through the close cooperation
of mentors in both locations and regular exchange visits. The dual-site training, which regular includes
exchange visits, is a particular strength of the proposed training program as it will provide exposure to multi-
institutional and multi-disciplinary collaborative research that builds on the expertise and long-standing
collaboration between UH and USC in research, education and training.

Public health relevance
Project Narrative The training program will educate postdoctoral fellows to investigate the behavioral, environmental and biological causes of cancer among ethnic/racial minorities and to work toward translating findings to reduce specific disparities in cancer risk and outcomes. Taking advantage of the Multiethnic Cohort, this training program will mentor postdoctoral fellows at the University of Hawaii Cancer Center and at the University of Southern California Norris Comprehensive Cancer Center.